Regulation of MutL-gamma function in mediating crossing over in mammalian meiosis

During prophase I of meiosis, crossovers (COs) ensure that parental homologs remain connected until the first
meiotic division, when they must segregate equally into two daughter cells. Errors in CO formation and
distribution are largely responsible for the very high rates of aneuploidy in humans. COs are initiated by
the formation of DNA double strand breaks (DSBs) in early prophase I, but the number of DSBs are in huge
excess relative to the final number of COs. In mammals, most COs are generated through the action of the
DNA mismatch repair (MMR) pathway, including the MutSγ (MSH4/MSH5) and MutLγ (MLH1/MLH3)
heterodimers. Of the 250 DSBs that form, ~150 load with MutSγ in early prophase I, and only ~ 23 of these will
load MutLγ later in prophase I to become the final CO sites. The paring down of MutSγ sites which then load
MutLγ must be exquisitely regulated to achieve a specific frequency and distribution of COs, and this lies at the
heart of “CO designation”. Recently, we identified Cyclin N-terminal Domain-containing-1 (CNTD1) as a critical
factor in determining which MutSγ sites load MutLγ, but the mechanism by which CNTD1 achieves the
appropriate frequency and distribution of COs across the genome remains unknown. Studies in our current
funding period have shown that CNTD1 interacts with components of the Replication Factor C (RFC) Complex.
RFC is a general name for one of four RFC variants which are loaders/unloaders of Proliferating Cell Nuclear
Antigen (PCNA). The PI’s lab has shown that PCNA is essential for mouse meiosis, and that post-translational
modification (PTM) of PCNA on lysine 164 is critical for this activity. However, nothing more is known about
how CNTD1, RFC, and PCNA function in concert to achieve CO designation and activation of MutLγ during
meiosis. Recently, we have demonstrated that PCNA interacts in vivo with RNF212B, a protein that functions
as an ubiquitin E3 ligase in cell culture, and knockout of which recapitulates the meiotic phenotypes of Cntd1
mutant mice. Thus, we hypothesize that CNTD1 regulates MutLγ activity and CO designation through
interactions with RFC and PCNA, collectively forming a “MutLγ Activation Cascade”. We further
hypothesize that the function of PCNA these events is dependent on the activity of RNF212B. Studies in
this renewal application are aimed at elucidating this important regulatory circuit in a stepwise manner. In Aim
1, we will investigate how CNTD1 recruits RFC and PCNA to CO sites. In Aim 2, we will define the unique
roles of each RFC variant in regulating PCNA loading/unloading during prophase I. In Aim 3, we will explore
the function of PCNA in driving MutLγ activation, testing two alternative models, and we will determine the
importance of PTMs of PCNA for these events. In addition, we will ask how RNF212B functions alongside
PCNA to drive its activity. These results will establish CNTD1 as a critical upstream regulator of CO
designation through its role in recruiting RFC and PCNA to facilitate MutLγ activation at a subset of MutSγ-
defined sites, significantly improving our understanding of the etiology of aneuploidy in human gametes.

Public health relevance
Crossing over is a hallmark feature of mammalian meiosis and involves the exchange of DNA between maternal and paternal chromosomes, hence tethering these homologs together until they must segregate equally into two daughter cells in preparation for the second meiotic division. Errors in crossing over can result in unequal chromosome segregation, leading to spontaneous miscarriages and birth defects in humans. Studies in the current proposal are aimed at understanding how crossovers are established, and what regulatory pathways ensure that crossovers are distributed appropriate across the genome to ensure equal segregation of all chromosome pairs.